Resource Support Program for AIDS Vaccine Development

The purpose of the Reagent Resource Support program for AIDS Vaccine Development is to support the activities required to produce, procure, store, ship, and maintain high-quality reagents, assays and/or services in support of preclinical and clinical AIDS vaccine research supported by NIAID, NIH, and/or various NGOs.